Computational Strategies for Deciphering Cellular Differentiation and Cancer Progression

Project Summary
Many diseases arise from molecular alterations within cellular mechanisms, and our understanding of these
processes is limited. Single-cell measurement technologies provide rich molecular data but current
computational methods struggle with their complexity. Traditional approaches treat single-cell data as discrete
sets, obscuring subtle continuous biological phenomena. To address this, we developed Mellon, an algorithm
that offers a continuous representation of high-dimensional single-cell landscapes by inferring a continuous
density function, effectively characterizing the distribution of cell states in a biological system.
This proposal aims to develop robust tools for modeling and interpreting single-cell data using cell-state
distribution representations (Aim 1) and novel specialized single-cell data representation (Aim 2). Our approach
will uncover complex mechanisms of cell differentiation and analyze new modalities like perturb-seq in greater
depth. We will demonstrate the utility of our methods with new datasets from collaborations, focusing on
hematopoiesis, tissue regeneration and homeostasis in liver, and massive Perturb-seq assays.
Aim 1 focuses on developing applications based on Mellon's cell-state distribution representation. This includes
tools for differential cell-state abundance, massive relational analysis of Perturb-seq data, local co-regulatory
mechanism analysis, and inferring cell-differentiation dynamics using partial differential equations.
Aim 2 involves developing computational representation of tissue using cell-state distribution, enabling online
learning, sampling strategies, and meaningful gradient estimates. We also aim to use hyperbolic spaces to
reduce the computational footprint without sacrificing biologically meaningful signals.
By addressing current limitations in data representation and analysis, this project will provide advanced
computational tools for single-cell analysis, leading to a deeper understanding of cell differentiation, disease
progression, and insights from large perturbation assays. The outcomes will significantly contribute to
developmental biology, regenerative medicine, and disease modeling, paving the way for new therapeutic
strategies.

Public health relevance
Project Narrative This project aims to develop computational tools for single-cell data analysis, addressing the limitations of current methods by leveraging advanced techniques like Mellon's cell-state distribution, hyperbolic embeddings, and differential equations linking cell-state dynamics to distribution changes, we seek to uncover complex biological mechanisms underlying cell differentiation, disease progression, and tissue regeneration. The outcomes will significantly advance our understanding of developmental biology, regenerative medicine, and disease modeling, leading to novel therapeutic strategies.